Multimodal Molecular Imaging of Choroidal Neovascularization

PROJECT SUMMARY/ABSTRACT
Wet age-related macular degeneration (AMD) is the leading cause of irreversible blindness in the
developed world. Choroidal neovascularization (CNV) is the leading cause of vision loss due to AMD. Although
anti-vascular endothelial growth factor (VEGF) therapy has shown a great breakthrough in CNV treatment,
persistent disease activity (PDA) is common. PDA has been demonstrated in 53% and 71% of patients treated
monthly with ranibizumab and bevacizumab, respectively. 20% of patients become legally blind and another
30% suffer from some degree of vision loss after 5 years of anti-VEGF therapy. While AMD is a serious problem,
one critical barrier limiting the ability to test novel therapies in preclinical settings is the lack of CNV animal
models with PDA and the lack of methods for longitudinal monitoring of disease biomarkers and response to
therapy. The goal of this project is to develop state-of-the-art multimodal molecular imaging for non-invasive
and longitudinal assessment of the imaging biomarkers in a new CNV rabbit model with PDA to offer a platform
technology for the development of novel therapeutics.
We have developed a high resolution, multimodal ophthalmic imaging system incorporating
photoacoustic microscopy (PAM), optical coherence tomography (OCT), and fluorescence microscopy (FM).
Novel chain-like gold nanoparticle clusters have been developed and used to enhance molecular imaging and
target integrins present in CNV. We have also developed a robust animal model of PDA using older rabbits that
demonstrate minimal response to anti-VEGF therapy. Encouraged by these exciting preliminary results, we
propose to further develop this platform molecular imaging technology for AMD with a central hypothesis that
a multimodal molecular imaging system that can evaluate the CNV animal model could contribute to
understanding the fundamental biology of AMD and the development of new pharmaceutical therapies to treat
CNV. We will test our hypothesis with the following Specific Aims: Aim 1: Upgrade the multimodal PAM, OCT,
and FM system for real-time imaging in rabbit eyes. Aim 2: Test the prediction that young rabbits with robust
response to anti-VEGF demonstrate capillary CNV while older rabbits demonstrate arteriolar CNV that can be
visualized with multimodal imaging. Aim 3: Test the prediction that the rabbit models of CNV in response to anti-
VEGF can be visualized at a molecular level with multimodal imaging powered by ultraminiature chain-like gold
nanoparticles. The results of this work will include concepts, tools, and strategies for future research across
several disciplines: a) Fundamental biology of AMD to visualize and quantify, with high spatial and temporal
resolution, functional and molecular changes in living animals. b) Strategies for testing and developing novel
drugs and non-pharmaceutical therapies in large eye models, particularly for CNV with PDA. c) Improved
prognostication research to enable real-time molecular biomarkers of treatment response.

Public health relevance
PROJECT NARRATIVE This project optimizes a new, safe imaging technology using a combination of light and sound in large animal eye models of wet macular degeneration. Imaging characteristics predicting lack of response to treatment are determined, and new nanoparticles for enhancement of imaging which are able to be safely excreted in the urine are evaluated. The long term goal of this project is to develop a multimodal molecular imaging using gold nanoparticles to image biomarkers predicting response to treatment to develop novel therapies of eye diseases.